Increasing Eye Care Utilization in Black Americans At High Risk For Glaucoma Using A Community-Engaged and Faith-Based Intervention

PROJECT SUMMARY/ABSTRACT
There are significant gaps in our understanding between well-established, evidence-based guidelines for
detection and treatment of glaucoma and effectively applying those guidelines within the high-risk populations
that continue to develop blindness. As outlined by the National Academy of Medicine, great opportunity exists to
incorporate principles of population health and community engagement to close this observed glaucoma
detection gap. The overall objective of this study is to design and implement a faith-based, community health
worker-delivered (CHW) support program for individuals at high risk for glaucoma, specifically Black Americans.
The central hypothesis is that a personalized faith-based support program will result in increased eye care
utilization in Black Americans at high risk for glaucoma who currently underutilize eye care. The rationale is that
increasing appropriate eye care utilization in high-risk individuals and beginning treatment at earlier stages of
the disease will decrease the risk of unpreventable blindness. The candidate will reach the overall objective by
achieving the following 2 specific aims: 1) Use implementation science framework and community-engaged
methods to adapt an existing glaucoma coaching program and develop a multilevel intervention that addresses
the key determinants of successfully increasing eye care utilization in Black Americans; and 2) Implement and
evaluate the feasibility and acceptability of the Community-Based Treatment for Glaucoma program (ComBaT
Glaucoma), for Black Americans. In Aim 1, the Tailored Implementation for Chronic Diseases (TICD)
implementation science framework will be used to guide semi-structured interviews with community members,
leaders, and local eye care providers to identify barriers and potential facilitators of increasing eye care utilization
in Black Americans; and b) adapt the Support, Educate and Empower (SEE) Program to the needs and culture
of the community to develop and the faith-based CHW-delivered program that uses implementation strategies
and behavior change techniques linked to community-identified determinants for optimal success. In Aim 2, the
ComBaT Glaucoma program will be implemented by conducting a single-arm pilot study with 50 Black
Americans. The candidate will use mixed methods to assess the feasibility and acceptability of the ComBaT
Glaucoma program. This study is significant because it addresses a gap between well-established guidelines for
glaucoma and high-risk individuals that continue to go blind despite these data. It is innovative because it
employs implementation science framework, a community-engaged, faith-based tailored approach to create a
support program to increase eye care utilization in Black Americans at high risk for glaucoma. Dr. Elam will use
the skills acquired during this training award to become one of the few ophthalmologists trained in implementation
science and community-engaged health disparities research to improve glaucoma care for all people in the
United States.

Public health relevance
PROJECT NARRATIVE Despite effective treatments and guidelines for care, glaucoma is the leading cause of blindness in Black Americans and represents a major disparity in health and health care. The proposed research advances public health by taking a community-engaged, population health approach to address the substantial public health gap between well-established guidelines for detecting and treating glaucoma and studies that document applications of these guidelines. This project aligns well with the missions of the NIH, NEI and National Academy of Medicine (NAM), as it works toward the elimination of preventable vision loss by approaches that go beyond the typical clinical setting.